Resilience/Resistance to Alzheimer's Disease in Centenarians and Offspring (RADCO)

Overall Summary
Centenarians delay age-related diseases and disabilities into their mid-nineties. Some remain
cognitively intact despite extreme exposure to the strongest risk factor for cognitive impairment
and AD, aging. The overall hypothesis of this study, titled “Resilience/Resistance to AD in
centenarians and Offspring” (RADCO), is: centenarian cognitive superagers and some of their
offspring have protective factors that confer such resilience or in some cases, even resistance
against cognitive decline and dementia. RADCO assembles an unprecedentedly large sample of
prospectively studied centenarian cognitive superagers (n=596), centenarians with normal
cognition (n=230), offspring superagers (n=480) and offspring spouses (n=144), who, via RADCO
cores, undergo careful, comprehensive and cutting edge neuropsychological, biomarker,
neuroimaging and neuropathological phenotyping. These data are used by two projects with the
overall scientific objective of gauging cognitive resilience in this sample, understanding the
underlying protective biology and translating that into therapeutic targets. The Cognitive
Resilience and Resistance Phenotypes Project (Project 1) gauges resilience by neuroimaging,
plasma AD biomarkers risk and neuropathology and therefore generates a range of resilience
endophenotypes. The Protective Factors and Mechanisms Project (Project 2) is the translation
arm of RADCO; it discovers genes, candidate biological pathways and sets of mi-RNA regulators
associated with the resilience endophenotypes characterized in Project 1. In-vitro models of AD
incorporate cortical neurons, microglial cells and astrocytes created from centenarian cognitive
superager induced pluripotent stem cell (iPSC) lines are used to test the candidate pathways for
how they cause resilience against AD.

Public health relevance
Centenarian cognitive superagers have exceptional cognitive function despite extreme exposure to the strongest risk factor for cognitive impairment and Alzheimer’s disease, aging. The “Resilience/Resistance to AD in Centenarians and Offspring” (RADCO) Study gauges cognitive resilience among centenarian cognitive superagers and their offspring using cognitive testing, neuroimaging, blood biomarkers, and neuropathology and translational studies will identify protective factors and underlying mechanisms that confer resilience or in some cases, even resistance against cognitive decline and dementia.